Interactive Digital Media-based Learning for Hand Hygiene in School-Age Children

Abstract
This project will iteratively develop and test a playable prototype of an interactive web-based handwashing game to
improve hand hygiene for elementary school-age children. The commercially released game will be playable on
smartphones, tablets, or notebooks, and will emphasize (1) how to wash--proper technique and duration; (2) when to
wash--before meals and after visits to the restroom; and (3) consistent application--establishment and maintenance of
good hygiene habits. All three components are necessary for effective hand hygiene.
Aim 1: Iterative Design. The project team will work with educational technology and clinical experts as co-designers to
develop a playable prototype game. The researchers will investigate the usability, engagement, and child focus on key
content.
Aim 2: Pilot Study. The developed intervention will be tried in a randomized control trial with elementary school
children attending after school programs, who have not seen the game before, compared to a control group of children
who attend the same after-school program, but do not receive the learning game intervention. Pre- and post-test
improvement in hand hygiene technique will be tested with a handwashing trial using UV-fluorescent ink, image capture
of washed hands, and quantification of ink remaining after washing.
Potential customers include after-school programs, school districts, as well as pediatric and family medicine clinics, that
seek infection control measures for hand hygiene that are effective, save provider or teacher time, and target both
English and Spanish speaking students and their families.

Public health relevance
Project Narrative Handwashing games for elementary school-age children, that actually improve handwashing performance in real-world practice, address an urgent unmet public health need. Schools are actively looking for infection control measures that will allow them to remain open in the midst of a pandemic, and proper hand hygiene is a low-cost, high-impact intervention to prevent disease spread—not only for COVID-19, but influenza, norovirus, and a host of other easily transmissible, and preventable diseases.